Time-Sensitive Research to Assess the Effects of Reproductive Health Policy on the Health Outcomes of People with Chronic Diseases

ABSTRACT
Nearly one-third of women in the United States have been diagnosed with at least one complex and chronic disease, and the incidence of multimorbidity is rising—including among pregnant women. Pregnant women with chronic and complex medical conditions are at particularly high risk of experiencing adverse reproductive outcomes, including severe maternal morbidity and maternal mortality. In addition, these women are particularly vulnerable to adverse reproductive outcomes as a result of state-level health policies; however, the effects of health policies on reproductive outcomes this population are largely unstudied. The INTREPID study will evaluate the time-sensitive impact of evolving health policies on the reproductive health and well-being of women, particularly those with chronic diseases that increase the risk of severe maternal morbidity and maternal mortality (e.g., cardiovascular disease, cancer, diabetes); the clinical practice and decision-making of physicians who provide healthcare for women with chronic diseases; and downstream reproductive outcomes at a population level. We will use survey-based, qualitative, and epidemiologic approaches to realize our Specific Aims, which are to: 1) Evaluate the intersections between health policy and reproductive health outcomes among women with chronic and complex diseases; 2) Assess, among physicians, the impact of health policy on medical decision-making and practice; and 3) Generate new evidence about the impact of health policies on population-based pregnancy outcomes (e.g., severe maternal morbidity, maternal mortality) and healthcare-related outcomes (e.g., prescribing of teratogenic medications, which may treat maternal disease but adversely impact neonatal health). The INTREPID research team has multidisciplinary expertise in medicine, obstetrics, health policy, qualitative methods, and epidemiology. Our project seeks to inform health policies that will optimize reproductive healthcare and clinical outcomes for women with chronic medical conditions and their families.

Public health relevance
NARRATIVE Our study will evaluate the evolving, time-sensitive impact of health policies on the experiences of pregnant women who have chronic and complex medical illnesses. The INTREPID Study will collect data from: 1) women with chronic diseases who are pregnant; 2) physicians who treat women with chronic diseases that have the potential to worsen in pregnancy; and 3) administrative health records to evaluate how different policy settings at the state level impact the health and well-being of women with chronic disease who are pregnant. Our findings will help inform health policies that support the health outcomes and healthcare of women with chronic diseases who are pregnant.